FAMily-centered WEight Loss for Black Adults (FAM WEL B-ing): Optimization and Evaluation using Multiphase Optimization Strategy (MOST) and Social Network Analysis (SNA)

The prevalence of obesity continues to be higher among Black adults compared to other racial/ethnic
groups in the United States, contributing to multiple health disparities. Strong evidence suggests modest
weight loss achieved through lifestyle behavior changes can reduce the burden of obesity-related conditions
like diabetes, cardiovascular health, and some cancers, yet current standard behavioral weight loss
interventions are not optimized for weight loss among Black adults. Cultural adaptation of these interventions is
recommended to improve weight and weight-related outcomes. Specifically, familial social networks are
considered an important obesity contextual factor to target for Black adults, providing opportunities for
provision of social support, resources for coping with stressors, and positive interdependence in achieving joint
goals. In the few studies incorporating family members in weight loss interventions targeting Black adults,
While this limited research shows promise, the field of family-centered
research in obesity has several areas in need of additional research, including identifying the most effective
combination of family support and behavior change strategies.
Our research team has previously developed and implemented family-centered behavioral weight loss
interventions for Black adults, including both couples and family member dyads.
weight loss outcomes are enhanced.
In these studies, we observed
clinically significant short-term weight loss and improvements in hemoglobin A1c; family interactions; dietary,
physical activity, and diabetes self-care behaviors; session attendance; and self-monitoring behaviors. Building
on these preliminary studies of multicomponent interventions, we propose applying two innovative
methodologies to optimize a family-centered behavioral weight loss intervention for Black adults. First, using
the engineering-inspired, Multiphase Optimization STrategy (MOST) and a highly efficient experimental design,
we will identify which levels and combinations of 4 intervention components yield the greatest weight loss at 6
months. Black adults (n=256 dyads, 512 individuals--index participant with %0,  30 kg/m2; dyad partner with
BMI  27.5 kg/m2) will receive a core behavioral weight loss intervention and be randomized to 4 additional
components: 1) number of family skills sessions (10 vs. 5), 2) delivery mode (in-person vs. online), 3) family
communication/conflict skills training (yes vs. no), and 4) family cohesion skills training (yes vs. no). Second,
by augmenting the optimization trial with Social Network Analysis (SNA), we will identify the types of
interactions dyad members have with their larger social networks (both family and non-family) and how these
interactions influence their health and weight loss behaviors. Evidence generated will yield an optimized family-
centered intervention for Black adults that can be fully evaluated in a subsequent randomized controlled trial.

Public health relevance
PROJECT NARRATIVE Standard behavioral weight loss interventions have been less effective for Black adults, who have the highest prevalence of obesity and would benefit from interventions that address important cultural factors. Family- centered behavioral weight loss interventions address the cultural significance of the familial social network in weight loss among Black adults and the need to move beyond individual approaches for health behavior changes in chronic disease management. We propose a study using the Multiphase Optimization Strategy (MOST) to determine the optimal combination of family components and component levels, and Social Network Analysis (SNA) to identify how interactions within social networks (family and non-family) influence individual behaviors among Black adults in a family-centered behavioral weight loss intervention.